Genetic dissection of defensin signaling in urinary tract infections

PROJECT SUMMARY
Urinary tract infections (UTIs) are commonly caused by uropathogenic Escherichia coli (UPEC) and affect
millions of patients, especially elderly women. Antibiotics do not reliably eliminate uropathogens and there is an
urgent need for more effective treatments to improve UTI patient outcomes. Thorough understanding of microbe-
host interactions in the urinary system will be key to the development of next generation immune therapies.
Antimicrobial peptides (AMPs) are a key component of innate immunity, but the functions of these peptides have
been very difficult to study due to the lack of animal models. The largest mammalian AMP family, the defensins,
has >50 members in mice, and deleting any single gene does not result in a strong phenotype. In my postdoctoral
work, I solved this problem by generating a Defensin cluster knockout (Def cKO) mouse line removing all Def
genes in select tissues. My previous work focused on skin immunity and established the necessity of defensins
and novel defensin receptors in anti-bacterial immunity. In my independent lab, I will shift my focus from the skin
to a niche that is entirely new to me – the urinary tract. In this Stephen J. Katz application, I propose to utilize
unique and innovative genetic tools to analyze the functions of defensins and defensin receptors in a mouse
model of UTI. We hypothesize that defensins are important for anti-UTI immunity, but are also a main cause of
UTI-mediated pelvic pain. We have three independent aims: Aim 1 will examine whether defensins synthesized
and secreted by bladder epithelial cells contribute to the epithelium’s immunity against UPEC invasion. We will
study defensin interactions with both intracellular and extracellular bacteria. Aim 2 will systematically characterize
the defensin-related immune response in UTI using single cell RNA sequencing (scRNAseq) analyses and
compare infected bladder tissues of wild type (WT) and Def cKO animals. This will allow us to identify all cell
populations whose numbers and transcriptomes are altered by the lack of defensins. We will then focus on a few
innate immune cell types with known defensin receptors, neutrophils, mast cells and dendritic cells, and explore
the significance of defensin-immune cell signaling in urinary immunity. Aim 3 will test the hypothesis that
defensins released in the bladder during UTI activate urinary nociceptive neurons and contribute to UTI-mediated
pelvic pain. We will measure pelvic pain behaviors and urination frequencies of UPEC-infected WT and Def cKO
mice as well as mice whose defensin-responsive neurons are genetically removed. The proposed project will be
the first comprehensive loss-of-function analysis of defensins in the urinary system. This will also be one of the
first surveys of neuroimmune crosstalk in the urinary tract. The immediate goal for this project is to understand
the cell types and cell surface receptors that respond to defensins in UTI. The ultimate goal of my research
program is to develop better treatments for UTI by targeting specific immune defensin receptors to enhance
innate immunity while limiting painful side effects caused by neuronal activation.

Public health relevance
PROJECT NARRATIVE Antimicrobial peptides named defensins are detected in patient urine following urinary tract infections (UTIs), but their functions are not clear. We will utilize newly developed Defensin cluster knockout mice to reveal how defensins regulate urinary immunity and pain during UTI. Successful completion of the project will aid the development of immune therapies to treat UTI and the associated pelvic pain.